Cancer Deep Phenotype Extraction from Electronic Medical Records

DESCRIPTION (provided by applicant): Precise phenotype information is needed to advance translational cancer research, particularly to unravel the effects of genetic, epigenetic, and othe factors on tumor behavior and responsiveness. Examples of phenotypic variables in cancer include: tumor morphology (e.g. histopathologic diagnosis), co-morbid conditions (e.g. associated immune disease), laboratory findings (e.g. gene amplification status), specific tumor behaviors (e.g. metastasis) and response to treatment (e.g. effect of a chemotherapeutic agent on tumor). Current models for correlating EMR data with -omics data largely ignore the clinical text, which remains one of the most important sources of phenotype information for cancer patients. Unlocking the value of clinical text has the potential to enable new insights about cancer initiation, progression, metastasis, and response to treatment. We propose further collaboration of two mature informatics groups with long histories of developing open-source natural language processing (NLP) software (Apache cTAKES, caTIES and ODIE) to extend existing software with new methods for cancer deep phenotyping. Several aims propose investigation of biomedical information extraction where there has been little or no previous work (e.g. clinical genomic entities, and causal discourse). Visualization of extracted data, usability of the software, and dissemination are also emphasized. Three driving oncology projects led by accomplished translational investigators in Breast Cancer, Melanoma, and Ovarian Cancer will drive development of the software. These labs will contribute phenotype variables for extraction, test utility and usability of the software, and provide the setting for a extrinsic evaluation. The proposed research bridges novel methods to automate cancer deep phenotype extraction from clinical text with emerging standards in phenotype knowledge representation and NLP. This work is highly aligned with recent calls in the scientific literature o advance scalable and robust methods of extracting and representing phenotypes for precision medicine and translational research.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose research to enhance the ability of researchers to utilize data from unstructured medical records in their translational cancer research programs. The proposed software platform has the ability to enhance the health of the public by contributing new methods for advancing cancer research.